MECHANISMS UNDERLYING AMYLOID-BETA AND TAU PATHOLOGIES FOLLOWING TBI

PROJECT SUMMARY Traumatic brain injury (TBI) is a major cause of death and disability, especially among young people. Pathological processes involving the amyloid-beta (Aβ) peptide and tau protein are accelerated by acute TBI. Moderate to severe TBI substantially increases the risk of dementia of the Alzheimer type later in life. Aβ deposition is a major pathological hallmark of Alzheimer disease (AD) and pathological tau abnormalities are seen in AD and many other neurodegenerative conditions. These Aβ and tau abnormalities may also contribute to short-term adverse outcomes, as some forms of these proteins can have immediately neurotoxic effects. Additional studies have found that Aβ can cause or accelerate tau pathology under some conditions, thus Aβ may play a central role in both pathologies. However, the mechanisms underlying Aβ and tau abnormalities following TBI are incompletely understood, in large part due to the lack of an appropriate small animal model. Preliminary results indicate that experimental controlled cortical impact TBI in 3xTg-AD mice results in intra-axonal Aβ deposition in the injured fimbria and accelerated tau pathology in the contralateral hippocampus within 24 hours of injury. 3xTg-AD mice produce both human Aβ and human tau with mutations that accelerate pathology, but in our experiments they were injured at young ages before significant neuropathological abnormalities are normally present. The long-term objective of the proposed project is to test the central hypothesis that Aβ is a key mediator of adverse behavioral and neuropathological outcomes following TBI. The specific aims are 1) to determine the mechanisms responsible for accelerated Aβ deposition following TBI in the 3xTg-AD mouse model, 2) to determine if TBI-induced Aβ overproduction plays a causal role in tau hyperphosphorylation and accumulation, and 3) to determine the effects of TBI-induced acute Aβ accumulation on sub-acute outcomes including behavioral performance axonal injury, neuronal cell loss, and tau pathology. Methods used will include a) colocalization studies of amyloid precursor protein (APP) and Aβ with several proteolytic enzymes thay may cleave APP to produce Aβ. b) pharmacological or genetic inhibition of several potential Aβ producing enzymes, c) analysis of tau pathology in several lines of transgenic mice with and without human Aβ, d) assessment of behavioral performance in mice treated with Aβ-targeted therapeutics or with genetic manpulations that eliminate Aβ production. If successful, these experiments will result in an improved understanding of the mechanisms underlying Aβ and tau abnormalities following TBI. This may facilitate development of therapeutic strategies targeting Aβ and tau, which could ultimately improve outcomes and reduce the subsequent risk of dementia and adverse cognitive outcomes in TBI patients.

Public health relevance
RELEVANCE Traumatic brain injury- such as from motor vehicle accidents, falls, assault, or military operations- is a common cause of impaired thinking and memory immediately after the injury and increases the chances of developing Alzheimer's disease later in life. The goal of this project is to use genetically engineered mice to improve our understanding of the causes of these thinking and memory problems and increased risk of Alzheimer's disease. If successful, the results of the project may point to ways to develop effective treatments to prevent or reverse these problems in the future.